Ferroptosis sensitization in glioblastoma

Glioblastoma (GBM) is the most common primary malignant brain tumor and is ultimately fatal.
We have shown that targeting ferroptosis, iron mediated lipid peroxidation, is a promising and
effective treatment strategy in GBM models. This regulated form of cell death is inhibited by
glutathione peroxidase-4 mediated clearance of lipid radicals using glutathione as a substrate.
Glutathione is a tripeptide containing cysteine. Levels of intracellular cysteine, and its homodimer
cystine, are regulated by System Xc-, a cystine-glutamate antiporter that is highly expressed in
glioma. Our group and others have shown that targeting System Xc- induces ferroptosis in glioma.
Our published data has also demonstrated that dietary cysteine/methionine deprivation (CMD)
enhances the effects of ferroptosis-inducing agents and provides a survival benefit in glioma
models. System Xc- activity is therefore well poised to serve not only as a target, but also a
biomarker of response to ferroptosis. Positron emission tomography (PET) imaging is an
established technique for analyzing cancer progression based on metabolic activity. Fluorinated
glutamate, (S)-4-(3-[18F]fluoropropyl)-l-glutamic acid or FSPG, is a sensitive tracer for detection
of malignant brain tumors as shown by clinical PET imaging studies, and thus may be a useful
and accurate biomarker of CMD and pharmacologic System Xc- inhibition in glioma. Indeed, our
preliminary data has shown that brain sections from glioma-bearing mice on a chronic CMD diet
demonstrate differential uptake of FSPG when treated ex vivo. My laboratory has therefore
optimized in vivo FSPG quantification in orthotopic syngeneic murine gliomas using PET-CT to
investigate this application. Additionally, radiation, which is standard of care in GBM, can itself
induce ferroptosis. Our murine in vitro data suggests that CMD and radiation synergize to induce
ferroptosis. We therefore aim to show in preclinical studies using human GBM models that CMD
synergizes with external and brachytherapy radiation to enhance GBM cell death by ferroptosis.
We hypothesize that FSPG PET-CT imaging accurately detects glioma response to System Xc-
inhibition, and radiation synergizes with CMD to induce ferroptosis, resulting in glioma cell death.
We propose to undertake the following Aims: 1) Validate FSPG tumor uptake as a non-invasive
biomarker of glioma response to treatment with System Xc- inhibitors (CMD, erastin,
sulfasalazine); 2) Show that CMD synergizes with radiation to induce ferroptosis in glioma.
The K01 will provide me with focused training in radiopharmaceutical imaging and radiobiology to
enable my transition to an independent investigator, as we work to advance this line of research
into patient care, combining CMD and radiation with FSPG PET-CT monitoring.

Public health relevance
PROJECT NARRATIVE Here, we propose an innovative strategy to target Glioblastoma (GBM), an aggressive malignant brain tumor that is ultimately fatal despite standard of care, using a novel method of regulated cell death, ferroptosis. We will investigate using preclinical studies in murine and human tumors, whether combining radiation and dietary deprivation of ferroptosis precursors cysteine and methionine synergize to kill GBM tumor cells, and elucidate the role of FSPG PET imaging as a biomarker of CMD and System Xc- inhibitor responses; the results from which will have broad implications for advancing paradigms in cancer treatment.